Collaboration and Opportunities Component

Project Summary—Mentored Collaborative Opportunities
Mentored collaborative opportunities provided by C-STAR include sabbaticals and pilot grant awards. The
Specific Aims of this Center's mentored collaborative opportunities component are to: (1) Match junior
rehabilitation researchers with senior scientists at Shirley Ryan AbilityLab (SRAlab) for sabbaticals; (2) Develop
the mentoring skills of senior scientists to assure successful collaborative opportunities; and (3) Develop plans
with home institutions of visiting researchers to share responsibility for candidates' visits. Achieving these aims
will allow us to promote, support, and prioritize interactions between visiting researchers and C-STAR
investigators. We will develop agreements with the home institutions of visiting researchers that specify plans to
share responsibility for financial support of candidates' visits. In addition, we will draw on the mentor training
expertise of Northwestern University's Clinical and Translational Sciences Institute.
The Research Plan for mentored collaborative opportunities draws on scientist-mentors at laboratories to
support visiting rehabilitation researchers conducting pilot projects. A critical resource is the translational
research model of the SRAlab. Five unique Ability Labs™ focus on distinct aspects of human performance.
Within these Labs, 37 principal investigators collaborate with 71 physicians and 361 therapists as well as
investigators at numerous academic institutions across the United States. Several centers, including the
Regenstein Center for Bionic Medicine, the Center for Rehabilitation Outcomes Research, and the Center for
Aphasia Research and Treatment, have extensive experience mentoring early-career and junior investigators.
In developing this application, we considered critical issues such as the structure of mentoring relationships
and incentives to assure that they are sustained. We have budgeted two 0.5 FTE personnel for implementation
and outcomes per year for mentored collaborative activities. All SRAlab senior scientists will contribute 5% effort
to the P2C per year, which will be funded by SRAlab. This effort will include mentoring of C-STAR clients. We
will provide an honorarium for scientists from Northwestern University as compensation for their mentorship. We
will negotiate the logistics of on-site mentored collaborations with visiting researchers' home institutions and the
home institution's financial support of visiting researchers. We anticipate a 1:4 cost sharing arrangement with
host institutions covering 80% of visiting scientists' expenses, with exceptions for institutions serving historically
disadvantaged populations; we will provide up to $50K to support sabbaticals for individuals from such
institutions. We will make substantive and sustained efforts to recruit scientists from minority backgrounds,
including those located at historically black colleges and universities and from Native American and Hispanic
backgrounds, as well as trainees with disabilities. Applications from visiting researchers will include a career
development plan that specifies the skills they wish to develop, their planned research project, and formal plans
for promoting, supporting, and prioritizing on-site interactions.